Physiological role of 16a- hydroxylated bile acid in energy intake and hepatic lipid metabolism.

PROJECT SUMMARY/ABSTRACT
Bile acids are regulatory molecules in energy intake and lipid metabolism. Controlling energy
intake and lipid metabolism are essential for human health, and these modifications can prevent
obesity and obesity-induced metabolic diseases. Structural differences, especially the hydroxyl
group position of bile acid, are crucial factors in determining the effect of bile acid on metabolism.
We have found that the 16α hydroxylation at bile acid enhances the production of bioactive lipids
involving energy intake and hepatic lipid metabolism in mice. However, the beneficial effect of 16α
hydroxylated bile acid in mammalian metabolism has not been investigated because the 16α-
hydroxylation at bile acid is not seen in mammals. In this grant, we propose to determine the
physiological role of 16α-hydroxylated bile acid in metabolism and underlying biology. How does
16α-hydroxylated bile acid regulate energy intake and lipid metabolism? How does 16α-
hydroxylated bile acid enhance bioactive lipids synthesis? We will use primary hepatocytes and
intestinal organoids culture, Seahorse for evaluation of mitochondrial function, reporter assay for
mechanism study, and tissue-specific knockout mice in this proposal. The success of this work is
expected to elucidate the specific targeting site of bile acid for the regulation of energy intake and
lipid metabolism.

Public health relevance
Project Narrative Bile acids (BAs) are promising potential drug targets for two metabolic epidemics of our era, obesity and diabetes. BAs are synthesized in the liver and promote lipid absorption in the intestine, and act as signaling molecules to mediate the control of energy expenditure, glucose homeostasis, food intake and hepatic lipid accumulation. This project aims to determine the potential effect of unique BAs, pythocholic acid in the behavioral and hepatic controls of energy balance and metabolism to establish foundational data for its putative therapeutic applications targeting the metabolic disease.